Research Project: Implementation Science and Health Services Core

PROJECT SUMMARY/ABSTRACT - Implementation Science and Health Systems (IS/HS)
Core
The Implementation Science and Health Systems (IS/HS) Core advances the scientific mission
of CAPS by equipping scientists with the skills and expertise to conduct research that brings
proven-effective interventions to scale in diverse settings. HIV intervention science now
includes a robust toolkit, including biomedical approaches for primary and secondary
prevention, effective behavioral strategies, and interventions to address social-structural
barriers to prevention and care. Unfortunately, many efficacious interventions have not yet
attained their full potential, owing to challenges in meeting the complex needs of vulnerable
communities who experience intersecting and co-occurring health and social conditions and to
inadequate integration of interventions into routine practice across health delivery settings and
systems. The IS/HS Core will build capacity within the Center for AIDS Prevention Studies in
applying implementation frameworks, designs, and strategies to integrate interventions and
services into both traditional and nontraditional settings to ensure service access for the
populations most in need. The Core reflects our belief that achieving optimal and equitable
delivery of HIV services requires research skills that draw on implementation and
dissemination theories, fluency in working within diverse health systems, and a commitment to
address intersecting and co-occurring health and social conditions. To do so, the IS/HS Core
takes an ecological and systems-level lens, focusing on the context of the populations served,
health care delivery settings, and stakeholders who can shape responses. Our work will be
guided by three aims: (1) to stimulate rigorous research to optimize intervention
implementation through a focus on implementation theory and intervention implementation
strategies, adaptation, and refinement; (2) to promote expertise in integrating interventions
within diverse health delivery settings through work to support program integration,
measurement, and data integration; and (3) to build capacity to sustain interventions in diverse
contexts via support for studying policy contexts, partnerships outside of health settings, and
promoting team science. The IS/HS Core will promote CAPS' objectives and the Core aims
through seminars, peer review, consultations, referrals, and town halls addressing critical
research topics. To this foundational mix of offerings, the Core will add novel approaches,
including skills-building workshops, multidisciplinary symposia, conferences, and growing a
multidisciplinary network of collaborators across UCSF, health systems, and community
agencies.